Thymosin Beta-4: A novel treatment for Acanthamoeba keratitis

PROJECT SUMMARY/ABSTRACT
Acanthamoeba castellanii causes Acanthamoeba keratitis (AK), a serious eye infection that can lead to gradual
vision loss, permanent blindness, and the need for keratoplasty. The parasite releases proteases that degrade
host cell membranes. In response, host cells undergo apoptosis and secrete pro-inflammatory cytokines. A.
castellanii has two life cycle stages, metabolically active amoebae and environmentally stable cysts. According
to the CDC, both forms may be found in soil, fresh or sea water, sewage, swimming or medicinal therapy pools,
dental treatment units, dialysis machines, heating/ventilation/air conditioning equipment and contact lens
equipment and solutions. The majority of AK cases (~85%) occur in contact lens wearers. In
immunocompromised hosts, A. castellanii can also cause opportunistic infections, such as granulomatous
amoebic encephalitis (GAE), skin lesions, and nasopharyngeal, lung, and kidney infections. The importance of
this pathogen is exemplified by an increasing number of reported cases, especially AK and GAE, both of which
are challenging to diagnose and treat because of a lack of standardized treatment protocols and efficacious
therapies. No single AK drug can eradicate both forms of the pathogen and also be non-toxic to the tissues of
the eye. Thymosin β4 (Tβ4) is a small (4.9 kDa) actin-binding protein that is ubiquitously expressed in higher
eukaryotes but may be absent in lower eukaryotes. In addition to actin-binding, the peptide is also secreted and
can increase angiogenesis and cell proliferation, while inhibiting apoptosis and inflammation. Importantly, Tβ4
has been shown to promote corneal wound healing and reduce corneal inflammation. Topical Tβ4 has been used
to treat an animal model of bacterial keratitis, was the subject of a completed US phase 3 clinical trial for the
treatment of dry eye syndrome and is the subject of a current US phase 3 clinical trial for neurotrophic keratitis,
a degenerative corneal disease. Given these advanced ophthalmic uses, we hypothesize that Tβ4 is a viable
novel treatment for AK. We will test this hypothesis in two Aims. In the first aim, we will calculate IC50, minimum
inhibitory constant (MIC) and onset of action in vitro using infected cultures of immortalized retinal (RPE-1) and
corneal (HCE-S) cells. We will also determine the effect of Tβ4 on parasite virulence functions (e.g., stage
conversion, adhesion, secretion). On the host side, we will measure apoptosis and cytokine release in the
presence of parasite and peptide. In the second aim, we will employ two innovative ex vivo models of disease,
a porcine corneal button model and a 3D human corneal tissue model. Tissues (3D human model or animal eye)
will be infected with A. castellanii and subsequently treated with Tβ4. Histopathology and qPCR of
Acanthamoeba 18S rRNA will be performed on both models to determine resolution of pathology and reduction
of Acanthamoeba infection, respectively. At completion, we expect to have defined the efficacy of Tβ4 in the
context of AK. The project will have beneficial impact because they will provide a strong mechanism-based
proof-of-principle for the further development of topical Tβ4 as a novel treatment for AK.

Public health relevance
PROJECT NARRATIVE Acanthamoeba castellanii is an amoeba that causes Acanthamoeba keratitis (AK), a serious eye infection that can lead to gradual vision loss, permanent blindness, and the need for corneal transplants. The proposed studies will explore the efficacy of thymosin beta-4 (Tβ4) as a new treatment for AK. The project will discern the effect of Tβ4 on parasites, host cells, and 3D culture models of AK.